CD8+ T CELLS AND PROTECTION AGAINST VAGINAL CHALLENGE INDUCED BY SIVMAC239DELTA3

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Animals have been followed for disease progression with respect to viral loads, CD4-positive T cell depletion and SIV-specific humoral and cellular immune responses.